NMR Structure of Peptide and Protein Complexes Supplement

Abstract
The overall objective of the project is to contribute fundamental understanding of the exquisitely selective
recognition of protein tyrosine kinases for their protein substrates. Selectivity is generated from multiple factors.
One factor is spatial localization of the kinase to the proper regions in the cell through docking interactions
often mediated by domains independent of the catalytic domain. A second factor is amino-acid sequence
recognition of the substrate polypeptide chain near the cleavage site. Protein kinases play a major role in
disease and are second to only G-protein coupled receptors for the most targeted protein group for drug
development. Among all protein kinases, tyrosine kinases occur most frequently on a list of cancer-driver
genes, and are the most clinically targeted to date. The immediate objectives of this project are to 1) achieve a
physical rationale for a new entropy-driven allosteric phosphorylation mechanism that regulates tandem SH2
domains of Syk that dock Syk to membrane immunoreceptors; 2) determine if the tandem SH2 domains also
serve to localize Syk to cytoplasmic regions in conjunction with newly discovered functionalities of Syk; 3)
define the structure of the substrate polypeptide chain existing the C-terminal side of the catalytic site of Src
kinase and several other tyrosine kinases in order to evaluate a new perspective on kinase substrate
recognition determinants; and 4) identify new tyrosine kinase ligands that are substrate like and interact in the
shallow groove where the substrate polypeptide chain binds. To accomplish these objectives, a variety of
solution NMR studies will be conducted to characterize molecular interactions, define three-dimensional
structure and estimate thermodynamic parameters of tyrosine kinase-peptide substrate and tyrosine kinase-
protein substrate complexes. The NMR and biophysical analyses will be tightly integrated with computer
simulation methods selected to effectively explore large regions of protein conformational space. Finally,
chemical screening using a phosphorylation-based selection with DNA-encoded libraries of high complexity,
should identify new substrate-like inhibitor molecules of Src. The expected outcomes will advance scientific
knowledge on the physical mechanisms determining selective substrate phosphorylation by these key
enzymes in human health. Successful execution of the research plan would also identify small-molecule
ligands with potent and selective cellular activity, and impact future efforts to develop molecules useful for
studying disease in animal models or for cancer drug development.

Public health relevance
This project is to investigate the molecular processes that control the association of protein tyrosine kinases with other cellular proteins. Dysregulation of these associations can lead to aberrant function in immunological response, cell proliferation or cell survival, and lead to disease including autoimmune disorders and cancer. The value of the research is to provide knowledge that can be used to either fuel future efforts to understand disease through biosensors or develop effective drugs against autoimmune disease or metastatic cancer.